COVID-19 related inflammation as a risk factor for age-related cognitive decline and Alzheimer's Disease

PROJECT SUMMARY
More than 85 million cases of COVID-19 have been recorded in the US alone, and up to 40% of survivors
report Long-COVID symptoms including cognitive impairments. Together with evidence that inflammation
during adulthood increases risk for later cognitive decline, this raises the prospect that the COVID-19
pandemic will cause a future “second pandemic” in Alzheimer’s disease and age-related dementias. In this
project, we will identify specific mechanisms by which single stranded RNA (ssRNA) viruses (e.g., SARS-COV-
2) triggered innate immune signaling contributes to long-lasting memory impairments, exaggerated cognitive
decline during aging, and risk for dementias including Alzheimer’s disease. Our main goal is to determine the
impact of innate immune signaling as a consequence of ssRNA viruses on exaggeration of age-related
cognitive decline and risk for dementias including Alzheimer’s Disease. We will use a subchronic inflammation
protocol, established in my laboratory, together with behavioral tests of memory, protein biochemistry, and
gene expression assays to identify persistent changes in inflammatory state and neuroplasticity mechanisms
that exacerbate cognitive decline. We will use wild-type mice and APP/PS1 transgenic mice to determine
whether TLR7-induced inflammation causes acceleration of age-related cognitive decline and AD-like
pathology. Findings from this project will demonstrate how COVID-19, and other TLR7-induced inflammation
increases risk for dementia; identify sex differences in COVID-related vulnerability to cognitive decline; and
provide a basis for novel preventive strategies and treatments to reduce risk for Alzheimer’s disease and other
dementias in the post-COVID-19 population.

Public health relevance
PROJECT NARRATIVE Immune activation in the brain due to illness or injury increases risk for memory problems during aging and dementias including Alzheimer’s Disease. These long-term effects of inflammation on the brain raise the question of whether the COVID-19 global pandemic might cause a surge in Alzheimer’s disease cases in the decades to come. In this project, we will identify how a temporary sickness that mimics inflammation caused by mild COVID-19 cause long-term changes in brain function, memory impairments, and faster Alzheimer’s disease progression that emerge long after recovery from illness.